Molecular basis of viral DNA sensing through the cGAS-STING pathway

The Molecular Basis of Viral DNA Sensing through the cGAS-STING Pathway
The innate immune response is the first line of defense against bacterial or viral infections. Nucleic acids from
the pathogens serve as danger signals to the host and induce potent innate immune responses. The cGAS-
STING pathway plays a central role in sensing viral DNA. Upon DNA binding, cGAS is activated and catalyzes
the synthesis of a second messenger cyclic-GMP-AMP (cGAMP). The engagement of cGAMP by STING
initiates three lines of signaling events. First, the transcription factor IRF3 is activated and initiates the induction
of type I interferon (IFN-I). Second, the transcription factor NF-kB is activated, which synergizes with IRF3 to
promote the transcription of IFN-I genes and mediates the induction of proinflammatory cytokines. Third, the
activation of STING induces noncanonical autophagy, which is also important for the clearance of intracellular
pathogens. The molecular mechanism of the cGAS-STING pathway has been studied extensively over the last
few years. The crystal structure of cGAS bound to dsDNA demonstrates that cGAS is activated by DNA
induced oligomerization. The structures of STING bound to cGAMP and small molecule agonists reveal the
mechanism of STING activation upon ligand binding. The crystal structures of TBK1 and IRF3 bound to
peptides from STING C-terminal tail reveal the molecular bases of TBK1 and IRF3 recruitment and activation.
The structures of phosphorylated IRF3 provide insight into the mechanism of IRF3 activation by TBK1. The
cryo-EM structure of cGAS bound to the nucleosome core particle reveals the mechanism of cGAS inhibition
under resting condition. These comprehensive structural and functional studies significantly advanced our
understanding about the cGAS-STING pathway. Despite these extensive studies, many aspects of the cGAS-
STING pathway remain poorly understood. As a diffusible second messenger, cGAMP can be exported from
infected cells and imported by uninfected cells to induce the expression of IFNs. However, the structural basis
of cGAMP export remains to be determined. The exact mechanism of IRF3 activation upon phosphorylation by
TBK1 remains poorly defined. The activation of NF-kB plays a critical role in IFN-independent response
mediated by STING. However, the mechanism of NF-kB activation via STING in remains to be determined.
The proposed research will elucidate the molecular bases of several key events involved in the cGAS-STING
pathway with the following aims: 1). Elucidate the structural basis of cGAMP export by ABCC1; 2). Determine
the molecular basis of IRF3 activation upon phosphorylation; 3). Investigate the mechanism of NF-kB
activation via STING. The proposed studies represent a rigorous and comprehensive investigation into the
mechanisms of DNA sensing through the cGAS-STING pathway. It will dramatically advance our
understanding of the molecular basis of innate immunity against viral DNA and provide a foundation for
innovative approaches to treat viral disease, autoimmune disorder, and cancer.

Public health relevance
Project Narrative: Pathogenic viruses are still a major threat to human health. The activation of the cGAS-STING pathway by viral DNA results in the expression of type I interferons, an important family of antiviral cytokines. In the proposed studies, the PI will elucidate the molecular mechanism of several key events involved in the cGAS-STING pathway, which will provide insights into novel approaches to treat human diseases.